HazPrep Worker Training - Community Risk Profile

PROJECT SUMMARY/ABSTRACT A worker's personal hazard profile (PHP) is a function of hazards present and his/her exposure level to those hazards. Workers with an elevated level of risk are those who can be engaged in activities related to ­ or working around ­ hazardous materials, waste generation, removal, containment, transportation, and emergency response. inXsol believes two components are necessary to implement a sophisticated geo-­personalized, role-­based, all­-hazards-­training activity platform: PHP and cloud based automated community profile algorithms. Our approach solves a problem for communities (knowledge about local risks) and a problem for worker safety (hazards workers or responders can prepare for). The proposal includes innovative use of big data algorithms for community profiles and fusion with PHP allowing for targeted and personalized training into a platform we have named HazPrep.

Public health relevance
The research and development project proposed will improve worker health and safety by delivering personally localized risk awareness and mitigation training. The dynamically localized and innovative cloud based active social components will both yield a deeper engagement with the content and foster creation of peer connections that may not be developed otherwise in advance of an incident. The resulting curated content enriches subsequent learner experiences.